Developing a local Retail Food Safety Program Plan using the Voluntary National R

Project Summary/Abstract In 2012, the City of Berkeley Division of Environmental Health completed an updated self assessment of the retail food safety program using the Voluntary National Retail Food Regulatory Program Standards (Retail Program Standards) and identified areas for improvement. In summary, the assessment identified the need for a written program plan with administrative policies and procedures. This project will focus resources to develop a Retail Food Safety Program Plan to meet Standard No. 2 (Trained Regulatory Personnel), Standard No. 3 (Inspection Program Based on HACCP Principles), Standard No. 4 (Uniform Inspection Program), Standard No. 5 (Foodborne Illness Investigation, Food Security, and Response), Standard No. 6 (Compliance and Enforcement) and Standard No. 7 (Industry and Community Relations). The first year of the project will focus on meeting Standard No. 2 by conducting a baseline survey of all retail food facilities, developing an inspection program based on Hazardous Analysis Critical Control Point Principles, and developing a training program plan to standardize inspections. The second year of the project will focus on meeting Standard No. 5 by developing and exercising a Foodborne illness and Food Security Preparedness Response Plan. The response plan will be amended based on the evaluation of the exercise. The third year of the project will focus on completing Standard No. 7 by conducting a community food survey and developing a community relations program. The fourth year of the project will focus on completing Standard No.4 by developing and implementing a quality assurance program. The fifth year of the project will focus on completing Standard No. 6 by developing a Compliance and Enforcement plan and completing FDA Retail Program Standards verification audits.

Public health relevance
Project Narrative The goal of the project is to develop a Retail Food Safety Program Plan that complies with the FDA Voluntary National Retail Program Standards to reduce the occurrence of CDC risk factors linked to foodborne illness and improve the effectiveness of the local regulatory program. Having a comprehensive plan in place will improve program effectiveness, promote active managerial control by food facility operators and will reduce the incidence of CDC risk factors. This will lead to fewer cases of foodborne illness thereby improving public health outcomes. __SpecificAimsTextDelimiter__ Specific Aims The aim of this project is to use the 2012 Retail Program Standard self assessment as a guide to focus staff resources to work to develop and implement a comprehensive Retail Food Safety Program Plan. The program plan will adopt and sustain the FDA Retail Program Standards through various written administrative policies and procedures. By doing so Berkeley will improve the effectiveness of the local retail safety food program, reduce CDC risk factors at retail food facilities and promote active managerial control by facility operators. This effort will lead to disease prevention and improved public health outcomes for the community. The project will use the 2012 self assessment to guide the development and implementation of Retail Food Safety Program Plan to improve program effectiveness by completing the Retail Program Standards within the listed timeline. Objectives Task Delivered By Year 1 Meet Standard No. 2 and Standard No. 3 a) Conduct a Baseline Survey b) Develop Inspection Program based on HACCP Principles c) Develop Training Program Plan September 2013 Year 2 Meet Standard No. 5 a) Develop a Foodborne Illness and Food Security Preparedness Response Plan b) Exercise, evaluate and improve plan September 2014 Year 3 Meet Standard No. 7 a) Conduct community survey on food safety knowledge b) Develop an Industry and Community Relations Program to communicate food safety to community September 2015 Year 4 Meet Standard No. 4 a) Develop a quality assurance program September 2016 Year 5 Meet Standard No. 6 Complete Verification Audits of Standards a) Review policies and procedures; amend as needed to enforce program standards. b) Develop a compliance and enforcement plan c) Conduct verification audits for Standards 2, 3, 4, 5, 6, and 7. b) Publish results September 2017